The role of early educational contexts in differential genetic susceptibility to cognitive impairment and dementia

PROJECT SUMMARY
Although education is often cited as the most important protective factor against Alzheimer’s Disease and related
dementias (ADRD), most research in this area ignores the educational contexts in which that schooling took
place. Moreover, it has yet to consider whether and how early educational contexts shape the relationship
between genetics and ADRD, even though there is a strong genetic component to ADRD. Over the last several
years, I have been developing a research program to advance scientific understanding of the role of education
in dementia risk. This Mid-Career Independent Scientist (K02) award proposal builds upon this foundation by
expanding my expertise in education and ADRD to the field of genetics. My long-term career goal is to establish
myself as a national and international expert in ADRD. To achieve this goal, I have identified four objectives as
part of the K02 project: 1) develop knowledge of and advanced analytic skills in using genetic markers of ADRD
and polygenic risk scores for cognitive impairment and dementia; 2) cultivate new collaborations with established
social scientists who have expertise in using genetic data in population studies broadly as well as specific to
ADRD; 3) extend my currently funded research (R01AG067536) to examine how genetic susceptibility to
cognitive impairment and dementia interacts with early educational contexts and may result in differential risk for
cognitive decline and impairment; and 4) apply the data and knowledge gained from the K02 award to secure
additional R01 and P30-level funding to support my research program in ADRD and build institutional capacity
in aging and ADRD at the University of Maryland, College Park and the Washington D.C. area. To achieve my
K02 objectives, I have established a team of collaborators who are leading ADRD researchers or social scientists
with expertise in genetics and who will jointly contribute to my professional development as a gene (G) x
environment (E) researcher in ADRD. Further, I have the institutional support and environment necessary to
carry out the project. The K02 award will accelerate my research program and establish me as a senior
investigator in aging and ADRD by providing me with protected time to develop strategic collaborations, skillsets,
and knowledge in the genetic and biological underpinnings of ADRD. Findings from the K02 project will advance
scientific understanding of how genetic and environmental factors interact and result in differential brain health
and functioning, an NIA research priority area, and can inform policies aimed at reducing dementia prevalence
in future cohorts of older adults. Importantly, my prior scholarly, funding, and mentoring success provide
evidence that I can translate the protected time and training provided by the K02 into exponential professional
growth and scientific impact.

Public health relevance
NARRATIVE The proposed research will provide important insights into the genetic and social/environmental factors that produce optimal brain health by considering the fundamental role that state-level educational contexts play in genetic susceptibility to cognitive impairment and dementia. The proposed research is relevant to several NIA priorities in the area of Alzheimer’s Disease and related dementias (ADRD), including the intersection of genetics and the environment for ADRD risk and identifying early life risk and protective factors for ADRD.